Nanotechnology as a therapeutic approach in arteriovenous fistula maturation

Arteriovenous fistula (AVF) maturation failure is a significant clinical problem in the hemodialysis patient
population. Targeted nanomedicine is a rapidly growing area of research that is a promising approach to treat a
wide spectrum of diseases, including cardiovascular disease and cancer. However, there is a paucity of research
regarding the use of targeted nanomedicine to treat or prevent AVF maturation failure. Moreover, a better
understanding of the pathways involved in AVF maturation failure is essential to develop novel therapeutic
strategies, including targeted nanomedicine.
The first objective of this proposal is to investigate the role of the transcription factor ETS proto-oncogene
1 (ETS-1), matrix metalloproteinase (MMP)-2, and MMP-9 in AVF development. Extensive work from our team
has provided a strong rationale that the ETS-1 and MMP-2/9 axis is a major driver of pathological AVF
remodeling. The second objective of this proposal is to investigate the effectiveness of drug-loaded P-selectin-
targeted nanoparticles (NPs) to treat or prevent AVF maturation failure. AVF maturation failure is a regional
problem, and therefore, targeted delivery of drugs to the AVF site may reduce dose-limiting toxicity, undesirable
off-target effects, and unfavorable pharmacokinetics due to rapid drug degradation. We have recently engineered
innovative NPs that display high affinity to P-selectin expressed in injured/activated endothelial cells. We found
that AVF creation surgery was followed by increased P-selectin expression at the AVF site and that P-selectin-
targeted NPs were preferentially aggregated at the AVF site. Furthermore, our team has developed various NPs
for drugs with different sizes and chemical properties. The NPs for small drugs are based on fucoidan (a
polysaccharide), which exhibits nanomolar affinity to P-selectin. The NPs for large drugs are based on liposomes
conjugated with P-selectin ligands. Both carriers are made of natural and synthetic biocompatible materials that
have been shown to be safe for use in humans.
Our long-term goal is to develop novel therapeutic strategies to prevent AVF maturation failure that can
ultimately be safely used in humans. Our central hypothesis is that maturation failure is caused by upregulated
ETS-1 and MMP-2/9, and that the blockade of this pathway using nanoparticle-targeted delivery of drugs can
improve AVF maturation. This hypothesis will be tested in two Specific Aims, using a combination of genetic
approach (Aim 1) and nanotechnology (Aim 2). Aim 1: To determine the causal role of ETS-1 and MMP-2/9 in
pathological AVF development in rodents with CKD. Aim 2: To investigate the therapeutic potency of ETS-1 and
MMP-2/9 inhibition by targeted nanomedicine in enhancing AVF development in rodents with CKD. This
translational project is innovative and significant, as it investigates a novel molecular pathway of AVF maturation
failure and uses a novel nanotechnology for treating/preventing this clinical problem. Successful completion of
these aims will identify important targets for developing innovative nanomedicine to enhance AVF maturation.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because up to sixty percent of arteriovenous fistulas created in hemodialysis patients in the United States fail to mature for successful dialysis use. This project aims to improve the understanding of the mechanisms of arteriovenous fistula maturation failure and develop nanomedicine to treat this important clinical problem. Thus, the proposed research is relevant to the NIH’s mission that pertains to developing fundamental knowledge to help reduce morbidity and mortality for patients on hemodialysis requiring a vascular access.